Targeted Proteomics Core

The Targeted Proteomics Core designs and implements targeted assays that have been used
increasingly by Center investigators to quantitate and validate potential protein biomarkers initially identified
from the protein profiling analyses carried out by the Discovery Proteomics Core (DPC); genomic studies,
including the use of neuronal cell type-specific transcriptional and translational profiling; or the literature. These
analyses will include relative and absolute quantitation of targeted protein levels or alterations in their post-
translational modifications (PTMs) that have been implicated in model and other organisms as adaptive
changes that occur in response to drugs of abuse. To address the huge level of cellular and sub-cellular
heterogeneity in the central nervous system, another objective is to develop the targeted workflows needed to
analyze subcellular organelles and sub-proteomes from the single types of neurons that define the circuits that
underlie the actions and addictive properties of drugs of abuse. In Aim 1 we will develop high throughput
Parallel Reaction Monitoring (PRM) assays to validate the most significantly differentially expressed proteins
and PTMs identified by the Discovery Proteomics core. Highly sensitive PRM assays also will be built to
examine the proteomes of specific neuronal sub-types and their organelles (e.g., nuclei, synaptic vesicles),
sub-cellular fractions or partially enriched samples (e.g., PSD). Eukaryotic proteins are almost always
assembled into multiprotein complexes in vivo and these complexes play important roles in neural signaling
and synaptic plasticity. Aim 2 will leverage the data from our targeted assays by using existing and
implementing improved proximity labeling (PL) technologies to identify protein interactomes in a cell type and
subcellular manner. To accomplish this aim we will optimize workflows for carrying out BAR, Turbo-ID, and
other PL approaches and work with the Biostatistics and Bioinformatics Core to improve PL data analysis
pipelines. In Aim 3, we will broaden the utility of PL for neuroproteomics applications by developing new
chemical probes for existing PL enzymes and alternate and orthogonal enzyme/probe pairs. This will involve a
combination of probe synthesis, protein engineering, and yeast display based directed evolution. In Aim 4 we
will continue to train Yale/NIDA Neuroproteomics Center members in PL and targeted mass spectrometric
techniques including experimental design, sample preparation and handling, digestion protocols, and
interpretation of PRM spectra and data so they can optimally utilize the advanced technologies available in the
Center.